Genetic dissection of fluid flow signaling in Left-Right patterning of zebrafish

Project Summary/Abstract
Fluid flow transduction pathways are critical for development, however it is little known how cells sense and
transduce fluid flow signals. Defects in flows and flow sensation result in developmental diseases including
primary ciliary dyskinesia, heterotaxy, and congenital heart disease. While the Polycystin transmembrane
proteins have been implicated in fluid flow sensation and transduction, few other proteins regulating flow
sensation and transduction have been identified. This study aims to characterize novel flow sensory pathway
regulators and build on the Polycystin flow sensory complex using the highly tractable left-right (L-R) patterning
system of zebrafish embryos. In this system an asymmetric fluid flow is sensed by ciliated cells and breaks L-R
symmetry by repressing a key target gene, dand5, leading to asymmetric expression of downstream genes. To
identify flow sensory pathway components in the L-R patterning system, I performed a reverse genetics screen
and identified several novel regulators. Focusing on four of these, my overarching hypothesis is that they
function as part of flow signal sensation or transduction, upstream of dand5 repression. I will test this
hypothesis through two Specific Aims: 1) Test the requirement of novel regulators for cilia formation, motility,
flow generation and flow sensory pathway output using a novel pathway sensor I am building and 2) Test the
hypothesis that pkhd1l1, or Fibrocystin, functions in flow sensation in cilia as part of the Polycystin complex.
Overall, this work will expand our understanding of flow sensory pathways by mechanistically placing novel
regulators into the L-R patterning pathway. Moreover, this work aims to build on the current Polycystin flow
sensory complex by dissecting Polycystin-Fibrocystin interactions, something which will have implications for
L-R patterning and kidney diseases.

Public health relevance
Project Narrative Extracellular fluid flows act signals, either by providing mechanical force or directing chemicals across cell surfaces, however, few proteins that sense and transduce fluid flows signals have been identified. The purpose of this research is to use the zebrafish left-right patterning system to characterize novel proteins that sense and transduce fluid flows. Through this work we will gain insight into diseases caused by aberrant fluid flows like polycystic kidney disease, heterotaxy, and congenital heart defects.